The impact of bacterial oxidative stress responses on the ecology and pathogenicity of oral streptococci

PROJECT SUMMARY/ABSTRACT
Bacterial diseases of the oral cavity (e.g. caries) are fundamentally polymicrobial, and understanding the inter-
action between different species of bacteria is central to understanding how the oral microbiota is modulated.
Among the most abundant bacteria in human saliva are Streptococcus species, some of which are dominant in
healthy individuals and some of which are associated with or more abundant during diseased states. Hypothio-
cyanous acid (HOSCN) is an antimicrobial oxidant abundant in saliva that is synthesized by mammalian heme
peroxidases from H2O2 and thiocyanate (SCN-). Saliva contains the highest concentrations of SCN- in the human
body (up to 3 mM), and the antimicrobial activity of the HOSCN produced by salivary lactoperoxidase (LPO) has
been known for over 60 years. Early biochemical experiments showed that that commensal, health-associated
oral streptococci (e.g. Streptococcus sanguinis) possess an enzymatic activity capable of degrading host-derived
antimicrobial oxidants, while the caries-associated pathobiont S. mutans does not.
We have recently identified a broadly-distributed bacterial HOSCN reductase (called RclA) that protects bacteria
against the antimicrobial effects of HOSCN. S. sanguinis encodes an RclA homolog, while S. mutans does not.
This now presents us with the opportunity to directly test the long-standing hypothesis that HOSCN reductase
activity is important in the competition between health- and disease-associated oral streptococci. Doing so, how-
ever, will also enable us to undertake a more careful examination and dissection of the role of LPO in modulating
the oral microbiota and its potential use as an antimicrobial to modulate early dental plaque biofilm development.
AIM 1. Identifying and characterizing HOSCN responses in oral streptococci
Using genetically-tractable strains of S. sanguinis and S. mutans and a newly optimized defined artificial
saliva medium, we will use molecular genetic, biochemical, and transcriptomic approaches to identify and
test the impact of individual genes (e.g. rclA in S. sanguinis) and pathways that contribute to the ability of
oral streptococci to respond to HOSCN. We will test the impact of these genes on the growth of HOSCN-
stressed single and dual-species cultures both planktonically and in surface-associated biofilms.
AIM 2. Characterizing the impact of LPO and its products on interactions between oral streptococci
The extent to which LPO’s impact on oral bacteria is HOSCN-dependent under physiological conditions is
unclear. We will characterize the impact of physiological concentrations of pro- and anti-oxidant products
found in saliva on interactions between S. sanguinis and S. mutans in artificial saliva, both during planktonic
growth and in surface-associated biofilms.
The results of this work will be the first molecular-level understanding of how the pro- and anti-oxidant compo-
nents of saliva drive growth and competition between cariogenic and non-cariogenic oral Streptococcus species.

Public health relevance
PROJECT NARRATIVE The interactions between oral bacteria and the host immune system have major impacts on human wellness. The research described in this proposal is aimed at understanding how bacteria that live in the mouth sense and respond to antimicrobial oxidants present in saliva and the enzymes that produce those oxidants. We expect the results of these studies to advance fundamental knowledge about how oral bacteria interact with each other and with the immune system, which, in the long term, will facilitate the development of new strategies to manip- ulate those interactions to promote human oral health.